E2 AND GH EFFECT ON PROTEIN SYNTHESIS AND BONE DEPOSITION IN TURNER SYNDROME

The hypothesis to be tested is that estrogen and growth hormone are synergistic in stimulating both whole body protein synthesis and bone deposition in Turner Syndrome in girls and adults.